Role of hopanoid microbial lipids in a legume:microbe nitrogen-fixing symbiosis

Project Abstract
It is well known that components of the bacterial cell wall are crucial to successful host
interactions for both pathogenic and beneficial microbes. While detailed mechanistic information is
available on the roles of a subset of cell wall components (i.e. lipopolysaccharides (LPS) and
peptidoglycan) in these associations, few other bacterial cell surface molecules have been as rigorously
investigated. Bacterial hopanoids are emerging as new determinants of the efficiency of the interactions
between a subset of bacteria and their eukaryotic hosts. Hopanoids are sterol-like lipids produced by
diverse eukaryote-associated bacteria, including the human pathogens in the Burkolderia cepacia
complex and Bacillus cereus spp. In addition to rigidifying bacterial membranes, similarly to eukaryotic
sterols, hopanoids are known to confer broad stress resistance to bacteria in culture. In native infection
contexts, the significance of the increase stress resistance provided by hopanoids, and whether hopanoids
confer other advantages, has not been mechanistically clarified.
Recent work in the Newman lab has demonstrated that a specific class of hopanoids, extended
hopanoids containing an extracellular hydrocarbon tail, regulates the efficiency of the symbiotic
interaction between the nitrogen-fixing bacterium Bradyrhizobium diazoefficiens with the legume host
Aeschynomene afraspera. I have determined that extended hopanoids affect the progression of the
symbiosis at all stages, including the initial bacterial infection of plant roots and subsequent proliferation
of bacterial symbionts within host cells. I hypothesize that the role of extended hopanoids during these
stages is to enhance bacterial growth under abiotic stressors, specifically the mechanical and chemical
pressures provided by the host niche. In my Research Plan, I propose to characterize further the role of
extended hopanoids in the B. diazoefficiens-A. afraspera symbiosis and to use this system as a model for
how hopanoids facilitate persistent infections of eukaryotic hosts more generally.
In my PhD I studied the nuclear actin cytoskeleton in human tissue culture models, using
approaches in quantitative microscopy and biophysics, and completing my Research Plan will require me
to significantly expand my skill set. I am applying for a K99 award to support the training I need to
develop both the research and non-research skills necessary to achieve my long-term career goal of
establishing a successful independent laboratory at an R1 institution. I hope to synthesize approaches in
biophysics, quantitative microscopy, plant cultivation and microbial physiology to study microbial
responses to the chemical and mechanical environments of their hosts. I believe that my training history
makes me uniquely suited to occupy this under-studied research niche, which I expect to yield key
principles of microbial adaptation to hosts that will be broadly applicable to many host:microbe systems.

Public health relevance
Project Narrative The surfaces of bacterial cells contain a diversity of molecules that help protect bacterial from external stresses. These molecules can also serve as the “molecular signatures” of bacterial cells, which can be detected by immune cells during a bacterial infection. While the roles of a few surface molecules during bacterial infection are highly understood, many more components of the bacterial surface remain uncharacterized, some of which may be suitable targets for antibiotic development. In this proposal I will investigate a promising new cell-surface mediator of bacterial infections, the hopanoid lipids, which are present in bacterial pathogens including the highly antibiotic-resistant Burkolderia cepacia complex and Bacillus cereus spp.